Neural Stem Cell-derived EVs for Improving Aged Brain Function

Project Summary
This project's primary goal is to develop a non-invasive, extracellular vesicle (EV) therapy for maintaining
better cognitive and memory function in old age. The project proposes to examine the effectiveness of
intranasal (IN) administration of EVs generated from human induced pluripotent stem cell (hiPSC)-derived
neural stem cells (hNSCs) for improving cognitive and memory function in a mouse model of aging. RNA-seq
and proteomic studies have confirmed the presence of miRNAs and proteins having neuroprotective,
antiinflammatory, and neurogenic properties in hNSC-EVs. Preliminary studies have suggested that IN
administration of hNSC-EVs results in their uptake by microglia and neurons in all brain regions and leads to
improved cognitive function in middle-aged mice, in association with diminished neuroinflammation,
adenosine monophosphate-activated protein kinase (AMPK) activation, mammalian target of rapamycin
(mTOR) inhibition, enhanced autophagy, and improved neurogenesis. Therefore, the rationale for the
proposed approach is that the miRNA and protein cargo of hNSC-EVs would activate beneficial signaling
pathways in target cells such as microglia, neurons, and neural stem cells in the aged brain, which, in turn,
would reduce neuroinflammation, enhance neuronal function and neurogenesis, and thereby improve
cognitive and memory function. The project will test the hypothesis that IN administration of hNSC-EVs in
early or late middle age will maintain better cognitive function in old age, and hNSC-EV administration in old
age will reverse cognitive dysfunction. Furthermore, it is envisaged that functional improvements with hNSC-
EV treatment in the aged brain will involve modulation of activated microglia with inhibition of NLRP3
inflammasomes, AMPK activation, improved mitochondrial function, mTOR inhibition, enhanced autophagy,
improved neurogenesis, and reduced synapse loss. Using a mouse model of aging, this project will first
investigate the effectiveness of EVs administered in the early or late middle age to prevent cognitive and
memory dysfunction in old age (Specific Aim 1). In Specific Aim 2, the effect of EVs administered in old age
for reversing cognitive and memory dysfunction will be measured. Then, to understand the role of microglial
modulation in hNSC-EV-mediated improved cognitive function, the effects of microglia depletion at the time of
EV administration will be examined in both middle-aged and aged mice (Specific Aim 3). Since microglia
depletion in the aged mice improves cognitive function, any additive effects of hNSC-EV treatment over the
effects of microglia depletion would suggest that hNSC-EVs also act on other neural cell types or pathways to
mediate therapeutic benefits. Two regions of the brain, the hippocampus, and the medial prefrontal cortex
(mPFC), will be analyzed in male and female aged mice. The proposed studies are highly relevant for
preventing and treating age-related cognitive and memory impairments in old age.

Public health relevance
Project Narrative There is a need to develop an effective therapeutic strategy that prevents or alleviates age-related cognitive dysfunction. Using a mouse model of aging, this proposal focuses on testing the efficacy of a non-invasive, intranasal administration of extracellular vesicles generated from human induced pluripotent stem cell-derived neural stem cells for maintaining better cognitive and memory function in old age. If successful, the approach would provide the benchmark for the clinical translation of extracellular vesicle therapy to combat age-related dementia in the future.